The Laminin Receptors in Kidney Fibrosis

Our overall goal is to define how cell-extracellular matrix interactions regulate kidney homeostasis in health and
disease. These interactions are studied from animals to molecules using transgenic mouse models, cell
biological and biochemical assays. We previously defined the contribution of laminin (LM) receptor integrins,
integrin α3β1 and α6 containing integrins, to ureteric bud (UB) development. Recently, we made an unexpected
novel observation that LM receptors regulate tubular epithelial cell inflammation and kidney tubulointerstitial
fibrosis in aged and injured mice. These new findings form the basis of this renewal.
Integrins are transmembrane receptors composed of α and β subunits that mediate interactions between cells
and ECM. There are 18 α and 8 β subunits, which form dimers with different ligand binding properties. Integrins
are classified into collagen, LM and RGD binding receptors and the principal LM binding integrins are α3β1,
α6β1 and α6β4. Ligand specificity is defined by the extracellular domain while the transmembrane domain (TM)
and the cytoplasmic tail mediate specialized functional intracellular signaling. In the last grant cycle, we showed
that deleting the integrin (Itg) α3 subunit in the UB causes minor morphological developmental abnormalities,
while deleting the Itgα6 subunit did not alter development. Mice lacking Itgα3 in the UB are highly susceptible to
kidney fibrosis after unilateral ureteric obstruction (UUO), while the integrin Itgα6-null mice develop severe
tubular dilatation and cellular apoptosis, but no fibrosis. Mice lacking all LM binding integrins in the UB (Itgα3/α6-
null) have the same developmental phenotype as the Itgα3-null mice, but with age they develop severe
tubulointerstitial fibrosis and inflammation. These mice are also susceptible to severe inflammation, fibrosis and
tubular apoptosis after UUO and chronic proximal tubule injury. Utilizing collecting duct cells from these mice,
we show that in addition to their classical adhesion functions, the LM binding integrins regulate epithelial cell
apoptosis, inflammation and collagen production. Excess collagen synthesis occurs when Itgα3 is deleted,
apoptosis when α6 is deleted and, in addition to these processes, inflammation occurs in Itgα3/α6-null mice. In
this proposal, we will investigate the mechanisms whereby the LM-binding receptors regulate renal tubular
epithelial cell responses to aging and injury. We will test the hypothesis that loss of kidney tubule epithelial
cell signaling from LMs, via α3β1 an α6-containing integrins, causes accelerated inflammation and
excessive fibrosis and apoptosis resulting in chronic kidney disease in the following aims: 1) Define the
mechanisms whereby loss of LM binding integrin signaling predisposes kidney tubules to chronic
kidney injury. 2) Determine the mechanisms whereby the loss of LM binding integrin signaling promotes
renal tubular epithelial cell apoptosis, inflammation and collagen production.

Public health relevance
We anticipate that this study will generate novel insights into the mechanisms whereby the laminin binding integrins protect the kidney tubules from injury and fibrosis. This knowledge is fundamental to our understanding of how the renal tubules function in health and disease.